WMAT-JHU NARCH X Application

PROJECT SUMMARY: The White Mountain Apache Tribe (WMAT) and Johns Hopkins University (JHU) have partnered successfully on NARCH I, III, V, VI, VII, VIII and IX. Each NARCH application has included an integrated focus on training and community driven research which has deepened our understanding of local and cross-tribal health disparities, produced new public health solutions and added to the continuous development of our innovative training model that combines student and faculty development. Overall goals of the WMAT-JHU NARCH X initiative are to: 1) increase the pool of trained American Indian/ Alaska Native (AI/AN) scientists and research professionals; 2) strengthen our partnership with JHU and other research institutions through innovative community-based participatory research combining WMA and western cultural and scientific knowledge and world views; and 3) field innovative, strengths-based and culturally driven research to combat major AI/AN health disparities. The WMAT-JHU NARCH X application includes four components to meet these goals: 1) a student and faculty development project that will integrate academic and field-based research training, and 2) three NARCH research projects to: a) address the growing burden of invasive and life-threatening Staphylococcus aureus and Group A Strep infectious diseases; b) reduce trauma-related risks for substance abuse and suicide, and c) address diabetes risk and protective factors among diabetic parents and their adolescent children through a family-based home- visiting intervention. The research projects are focused on tribal-specific priorities and designed to provide a supportive, multi-disciplined platform for training Apache investigators on broad scientific research methods. Methodological approaches and rigorous evaluation designs will contribute new cultural and scientific understanding to protective factor-based intervention development and outcomes in AI/AN settings. Apache scientists will build skills in: biomedical and behavioral sciences, qualitative and quantitative research methods, culturally grounded development and deep structure adaptation of strengths-based evidence-informed interventions; and, rigorous, culturally competent evaluation approaches. The studies are built upon previous NARCH research findings, will apply innovative methods and approaches, and tap cultural and community assets to address major AI health disparities across the lifespan with potential for intergenerational impact. Activities have been selected and will be guided by the existing White Mountain Apache NARCH Community Advisory Board.

Public health relevance
PROJECT NARRATIVE: The White Mountain Apache-JHU NARCH X builds on our 35-year partnership addressing tribal health disparities and promoting tribal health autonomy. For NARCH X, Apache students and faculty will receive training in public health, biomedical and behavioral sciences, and develop applied skills through three research studies addressing: emerging infectious diseases; family-based diabetes prevention; and, trauma as a root cause of American Indian mental health disparities.